Impact of naturally occurring osmolytes on protein structure and energetics

DESCRIPTION (provided by applicant): There is a lack in understanding about the role of characteristic mixtures of osmolytes in normal body function, and in many disease conditions, including diabetes mellitus and cancer. The long-term goal is to understand the normal and abnormal roles of these osmolytes in humans, and to design strategies for the use of osmolytes in the treatment and prevention of disease. This project's objective is to understand how non-specific (preferential) interactions contribute to the apparent necessity of osmolyte mixtures observed in vivo. It is hypothesized that the requirement for complex osmolyte cocktails is intrinsic to aqueous mixtures of proteins, nucleotide ligands, and osmolytes. The rationale is that this research provides the basis for understanding the role that osmolyte mixtures play in so many important normal and abnormal cellular processes. These include normal tissue function in kidney and brain, and the pathological impact of osmolytes in many diseases. The central hypothesis will be tested by pursuing Specific Aims that address the major reasons why complex osmolyte mixtures may be necessary: disparate impact of osmolytes on proteins and nucleotides, which leads to the necessity of the mixtures; and non-additive action of osmolytes, which leads to complex, non-linear behavior. The impact of osmolytes on protein-nucleotide systems will be quantified through high-throughput methods. Thermal melts and measurements of effective concentrations will be performed on microplates, and conventional approaches will be used to verify the results. The initial model proteins are adenylate kinase, dihydrofolate reductase, and carbonic anhydrase, in conjunction with small nucleotide ligands, including ATP, AMP, NADP, and others. Thirteen osmolytes that are common in humans and throughout nature will be used in binary mixtures. This project is innovative in its idea that pathological osmolyte mixtures are a contributing factor to many deadly diseases. We expect that knowledge of the effects of natural osmolyte cocktails on proteins and nucleotides will allow differentiating between deleterious and beneficial mixtures, and elucidate osmolytes' contributing role in many diseases. Such information would be very valuable in identifying targets for the manipulation of the osmolyte content of cells through medication, supplements, or diet. This project is significant, because it overcomes a major block in understanding cellular pathophysiology, namely the question of what new properties emerge when osmolytes are combined in their natural mixtures with proteins and metabolites, thus opening new opportunities of ameliorating disease. Additional benefits of this kind of research include an enhanced understanding of protein folding, of protein crystallization, and of drug formulation.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project investigates mixtures of osmolytes (small molecules that naturally occur in humans), and how some of these cocktails can lead to beneficial or detrimental effects on biomolecules. It is expected that these results will facilitate the search for efficient chemoprevention agents against various cancers, and other diseases in which osmolytes play a role. Narrative This project investigates mixtures of osmolytes (small molecules that naturally occur in humans), and how some of these cocktails can lead to beneficial or detrimental effects on biomolecules. It is expected that these results will facilitate the search for efficient chemoprevention agents against various cancers, and other diseases in which osmolytes play a role. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS About two thirds of all deaths in America are due to conditions that have lifestyle patterns as their major risk factors. Many of these diseases (including diabetes mellitus and cancers) exhibit characteristic alterations in the cellular concentrations of small organic osmolytes, which are normally used as protection against stress. Osmolytes can alter the conformation and stability of macromolecules - with the potential to upset many cellular functions. The current challenge is that nature consistently uses balanced osmolyte cocktails, indicating that mixing more than one osmolyte is necessary for normal function; but essentially nothing is known about how mixtures of osmolytes exert their protective or detrimental effects on macromolecules. This gap in knowledge prevents us from clearly understanding the full range of osmolyte effects, their roles in normal and disease states, and how they may be manipulated in treating disease and maintaining health. Our long-term goal is to understand the normal and abnormal roles of osmolytes in humans, and to design strategies for the use of osmolytes in the treatment and prevention of disease. The objective of this project is to understand how non-specific (preferential) interactions contribute to the apparent necessity of mixtures observed in vivo. Our central hypothesis is that the requirement for complex osmolyte cocktails is intrinsic to aqueous mixtures of proteins, nucleotide ligands, and osmolytes. As described in the progress report, we have discovered examples for interactions within these systems that challenge the idea that proper osmoregulation within protein-nucleotide systems were possible using a single osmolyte. The rationale for this project is that it provides the basis for understanding the role that osmolyte mixtures play in so many important cellular processes, including normal tissue function in kidney and brain, and the biochemical impact under pathologi- cal conditions, such as diabetes and various cancers, where osmolyte balance is disturbed. The PI's experience with osmolyte effects in both experiment and theory, combined with Dr. Pettitt's expertise in computer simulation and Dr. Bolen's long-standing experience with osmolytes, makes us ideally positioned to pursue this research. The following Aims test our hypothesis by addressing the major reasons why complex osmolyte mixtures may be necessary: Synergy between osmolytes, and disparate effects on proteins and nucleotides. Aim 1: Identify osmolyte mixtures that act synergistically at the protein surface. We hypothesize that synergistic (non-additive) effects on proteins are primarily based on competition between osmolytes at the protein surface. To probe for non-additive, synergistic energetics, we use high- throughput thermal melts of proteins (initially adenylate kinase, dihydrofolate reductase, and carbonic anhydrase) on microplates. The degree of competition of osmolytes at the surface is then derived using our structural thermodynamic approach that analyzes the experimental data via statistical mechanics. Aim 2: Determine interactions between osmolytes. An important emergent property of mixtures is the possibility that osmolytes may mutually enhance their efficacies. Interactions between osmolytes in the bulk solution can increase or decrease their effective concentrations, and thus alter their effectiveness as stabilizers or denaturants. We hypothesize that protecting osmolytes enhance each other's effective concentration, with bulky osmolytes being most efficient. We will measure the effective concentrations in binary mixtures of the major osmolytes that naturally occur in humans. Aim 3: Determine the impact of osmolytes on free nucleotides. The working hypothesis is that osmolytes affect free nucleotide ligands differently from proteins. We will compare osmolyte effects on binding and folding. Measuring then the effective concentrations (chemical activities) in aqueous mixtures of nucleotides and osmolytes will reveal to what degree the observed effects are due to osmolyte-ligand interaction. As ligands we use AMP, ATP, NADP, and other small metabolites. This project is innovative in its idea that pathological osmolyte mixtures are a contributing factor to many deadly diseases. Our systematic high-throughput approach significantly broadens the scope for quantification of biochemical reactions in complex solutions, aiding in the novel inclusion of ligand-osmolyte interactions. Aims 1 and 2 will identify sources of synergy and uncover the mechanism by which osmolyte mixtures affect protein stability in the absence of ligand. Aim 3 will reveal the degree to which opposing effects of osmolytes on proteins and nucleotide ligands exist. Covering the different kinds of interactions in mixtures of proteins, nucleotides, and osmolytes, the Aims collectively enable us to test our central hypothesis, and identify how the necessity for complex osmolyte mixtures arises in systems that combine typical cellular constituents. This new knowledge will lay the foundation for understanding the key roles that osmolytes play in health and disease, and for rational optimization of osmolyte cocktails in disease treatment and prevention. The fundamental understanding provided by our results makes practical and direct contributions to fields of protein folding, protein crystallization, and to pharmaceutical formulations involved in vaccine and protein drug stabilization. In the following section we describe in more detail that osmolyte mixtures are likely an important, but overlooked, contributing factor in many prevalent diseases in America.